Administrative Core

ADMINISTRATIVE CORE
ABSTRACT
The Administrative Core proposed represents a continuation of this effective Core that has helped lead to the
many successes of the Center through the current cycle of CCCR funding. The overall objective of this
Administrative Core is to provide oversight and management of the CCCR to ensure that the Center
accomplishes its goals, which are to conduct and disseminate high level clinical research informed both by state-
of-the-art clinical research methods and by clinical and biological scientific discoveries. The Core will consist of
an internal administrative organization under the leadership of the Center Director, Associate Director, Director
of the Methodology Core and Director of Program Evaluation. All individuals involved in administration of Center
affairs have experience in their areas of responsibility. There will be two administrative committees, Executive
and External Advisory Committees, which will have defined oversight roles. The Executive Committee will also
meet with a Patient Advisory Group. The Administrative Core will oversee and coordinate all Center activities,
including the weekly inter-disciplinary research meeting (Research Accelerator), monthly journal clubs, other
educational programming, and Committee meetings. We will have an independent evaluation of the program to
assess the quality and success of the interactions and services provided by our CCCR to the broader research
community, and will review act upon the findings in an ongoing, iterative manner. Among the aims of this Core
are to ensure allocation of appropriate resources to ensure CCCR progress, to carry out an outreach program,
to administer a Pilot & Feasibility grant program, to ensure that data sharing agreements are in place and utilized,
to formally evaluate whether the CCCR is meetings its goals and objectives, and to leverage university and
medical campus resources to enhance the functioning and impact of the CCCR.